Device Design and Development Core

PROJECT SUMMARY
The design and development of new experimental equipment, from electrophysiology to imaging to other
prototyping, is critical for progress in vision research. This core will provide custom design and manufacturing
for devices to interface new research technologies with their particular experimental preparations, to enhance
collaborative sharing of device solutions, and thus to leverage new experimental techniques and speed progress
in vision research. This core will provide the primary source of critical device, design and development of custom
experimental equipment to NEl-funded vision research in the laboratories of numerous investigators, and serve
as a centralized resource to promote shared device designs to facilitate entry into vision research and
collaboration. The machine shop, which is housed within the Fairchild Building, will serve as one key node for
providing this service. The machine shop will provide not only frequent services to construct innovative new
equipment used in specific approaches in vision research, but will also be called upon to provide device design
and development. In addition, the Core will facilitate design of specialized equipment to be fabricated via Stanford
and, where indicated, outside 3-D printing services. Computer assisted design (CAD) programming and expert
staff will be leveraged towards device development goals. The Core Director and Assistant Director have
extensive experience with device development and the management of these resources. An explicit aim of this
Core is to foster and facilitate collaboration and rapid sharing of progress among investigators by prioritizing
innovative and collaborative vision research projects and communicating access and activity to all.